Deciphering the Role of Chemokine Receptor CCR5 in Maternal Flavivirus Infections

PROJECT SUMMARY:
CCR5 is a chemokine receptor involved in leukocyte trafficking. We identified a neuroprotective role for CCR5
in the context of West Nile virus (WNV) infection both in mice and humans. In mice, we found that mice lacking
Ccr5 are significantly more susceptible to WNV-induced encephalitis compared to wild type (WT) mice. We
translated these results using human cohorts, where we found that individuals that naturally lack CCR5
(CCR5∆32 homozygotes) develop more severe symptoms following infection with WNV. Furthermore, we and
others have shown that this protective effect was not limited to WNV infection, but that the loss of CCR5
increased susceptibility to numerous other neurotropic flaviviruses, including tick-borne encephalitis virus
(TBEV), and Japanese encephalitis virus (JEV). ZIKV is of particular concern because of its
impact on pregnancy, with microcephaly and other congenital malformations, as well as fetal loss, stillbirth, and
preterm birth among the possible outcomes. In preliminary data, we found that the loss of CCR5 increases
susceptibility to ZIKV (a known teratogen) during maternal infections, resulting in poor pregnancy outcomes.
This was also true for WNV, a virus not known to impact pregnancy. In this application, we will test the
hypothesize that CCR5 is protective against flavivirus-induced congenital disease. This application will unravel
the mechanisms involved in CCR5-mediated protection during maternal flavivirus infections.

Public health relevance
PROJECT NARRATIVE: CCR5 is a chemokine receptor that has a critical role in neuroprotection against a wide range of neurotropic flaviviruses in mice and humans. In this application, we have identified a novel role for CCR5 in the context of pregnancy. This application seeks to unravel the mechanisms involved in CCR5-mediated protection during maternal flavivirus infections.